Pediatric Dose Optimization for Seizures in EMS (PediDOSE)

PROJECT SUMMARY / ABSTRACT
Equitable care for children with seizures is critical to optimize well-being and health outcomes; however, little is
known about existing health inequities in the emergency management and outcomes of children who are
experiencing a seizure. Identifying areas of inequitable care in the emergency management of pediatric seizures
at the patient and community levels in both the prehospital and emergency department settings can inform future
work to determine root causes, interventions, and the development of policies to improve equitable care. Through
this diversity supplement we aim to expand the aims of the parent grant by evaluating associations with risk
factors for receiving inequitable care and the management and short-term outcomes of pediatric patients
experiencing a seizure. The parent grant is a 20-site stepped wedge trial of standardized, age-based midazolam
dosing administration for children in the Emergency Medicine Services (EMS) setting who are experiencing a
seizure. Aim 1 of the supplement will evaluate the association between patient-level risk factors for receiving
inequitable health care and social determinants of health with the frequency of seizure activity on emergency
department (ED) arrival for pediatric patients transported by EMS for seizures. Aim 2 will evaluate the association
between patient-level risk factors for receiving inequitable healthcare and social determinants of health with
prehospital care, ongoing participation in research, ED interventions, and short-term outcomes. We hypothesize
that both individual-level demographics and social determinants of health will be associated with increased
frequency of seizures on arrival to the ED, need for additional interventions in the prehospital and ED settings,
and worse short-term outcomes. The diversity supplement candidate will serve as the principal investigator of
these aims conducted in a multi-site prospective clinical trial, will gain an in-depth understanding of conducting
health equity research in the prehospital setting, and will develop hypotheses for further research on reducing
health inequities in this population.

Public health relevance
PROJECT NARRATIVE To provide equitable care for all children experiencing a seizure, we must first understand what inequities exist that may influence the outcomes of children from vulnerable demographic groups and/or communities. By identifying inequities, we can then implement targeted interventions to ensure that all children receive equitable and efficient care regardless of their background or community.